Novel Gene Therapy for Critical Limb Ischemia and Limb Salvage in Vascular Occlusive Disease

Project Summary/Abstract:
Critical limb ischemia (CLI) is the most advanced stage of peripheral arterial disease (PAD). It manifests with
leg pain, decreased walking distance, non-healing wounds and gangrene. About 1/3 of CLI patients don't
respond to standard therapy and ultimately undergo major limb amputation. This critical unmet need demands
a solution. CLI causes >105 major limb amputations in the USA per year. Our overarching goal is to develop a
novel limb-salvage therapy. Gene therapy is a promising option to induce therapeutic angiogenesis, increasing
blood flow in ischemic limbs for repair. This approach has raised a great deal of hope for `no-option' CLI patients.
However, previous gene therapy approaches using naked plasmids encoding angiogenic factors, such as
VEGF and FGF, failed to show substantial clinical benefits. Moreover, early adenovirus-mediated gene delivery
systems raised concerns over safety. Hence, more efforts for the identification of alternative effective
transgenes and safe/efficient delivery vectors are crucial. Success of gene therapy for CLI requires activation
and participation of endogenous healing mechanisms including recruitment/homing of stem/progenitor cells to
ischemic tissue. Enhanced recruitment/homing depends upon a `hospitable' tissue microenvironment that is
receptive of endogenous regenerative cells. Our previous research discovered that in ischemia, homing for
these critical repair cells relies on specific cell-cell interactions via a panel of adhesion molecules, including E-
selectin/ligand pairs. The levels of vascular E-selectin in the ischemic limb tissues is down-regulated. We
hypothesize that E-selectin is pivotal in the recruitment of stem/progenitor cells necessary for
neovascularization in ischemic tissues. E-selectin can serve as a docking site for endogenous stem/progenitor
cells to anchor. The resulting downstream cell-cell signaling cascades can increase angiogenesis and tissue
repair/regeneration. We have recently demonstrated feasibility, safety and superior efficacy of E-selectin/AAV-
based gene therapy for improving limb perfusion, increasing neovascularization, decreasing ischemia, reducing
gangrene, minimizing tissue damage, augmenting regeneration of the ischemic skeletal muscle, and extending
running capacity, in murine models. In the clinical setting, we believe that such biologic effects can increase
functional walking capacity and prevent limb loss. We thus propose to induce a supportive tissue
microenvironment by priming endothelial cells in capillaries and other ischemic limb-tissue cells with the
adhesion molecule, E-selectin, using a safe and efficient AAV2 vector. We will utilize a clinically relevant mouse
model of CLI – the footpad gangrene, to test this novel gene therapy. The objectives are to validate and optimize
the translational protocol for a future large-animal pre-clinical study and conduct the requisite IND-enabling
GLP/GMP animal research for a subsequent pilot human study. The development of this novel gene therapy
may ultimately eliminate the need for most amputations by accelerating therapeutic angiogenesis and tissue
regeneration, and promises to revolutionize the treatment for PAD/CLI patients.

Public health relevance
Project Narrative Patients with no-option critical limb ischemia (CLI) face to major limb amputations and huge health care costs. We propose to develop novel gene therapy, which employs E-selectin to prime ischemic limb to increase neovascularization and regeneration in ischemic tissues while decreasing tissue damage. It will ultimately eliminate the need for amputation and transform the care for PAD/CLI patients.